Phosphoglycerate mutase 5 a mitochondrial serin/threonine phosphatase a novel target to mitigate GI-ARS.

Project Summary
Currently, there is a need for strategies that mitigate gastrointestinal acute radiation syndrome (GI-ARS). The
risk of large populations encountering radiation exposure is real and growing. Radiation induced oxidative stress
plays a significant role in inducing radiation toxicity in intestinal epithelial cells. However, mitigation of GI-ARS
requires mitigation of oxidative stress along with induction of epithelial regeneration by activation of WNT/β-
catenin signaling. Mitochondrial serine/threonine phosphatase, phosphoglycerate mutase 5 (PGAM5), is
involved in activation of oxidative stress along with inhibition of WNT/β-catenin signaling. PGAM5, located in the
mitochondrial membrane, inhibits nuclear translocation of NRF2 and thereby represses NRF2-dependent anti-
oxidant gene expression. Moreover, PGAM5 induces β-catenin degradation by dephosphorylating DVL2, a β-
catenin destruction complex. We have observed that pharmacological inhibition of PGAM5 using a novel small
molecule-based modulator at 24 hours post irradiation mitigates GI-ARS. We therefore hypothesize that
PGAM5 could be a potential target for mitigation of radiation induced oxidative stress and activation of β-catenin
signaling in intestinal stem cells. In this proposal, we will first examine the involvement of PGAM5 in intestinal
stem cell radiosensitivity by using pharmacological or genetic modulation of PGAM5 (Specific Aim 1). Using a
mouse model of GI-ARS and ex-vivo intestinal organoids, we will examine the involvement of PGAM5 in radiation
induced oxidative stress and modulation of WNT/β-catenin signaling in ISCs. In specific aim 2, we will
characterize the PGAM5 inhibitor treatment with a determination of an optimum dose and schedule for mitigation
of GI-ARS in both male and female mice. We will examine the general applicability of this strategy in young and
aged animals. Determination of mechanism of action and dose optimization study of PGAM5 inhibitor will
facilitate PGAM5 inhibitor as a medical countermeasure against radiation under the FDA’s Animal Rule.

Public health relevance
Project Narrative The proposed research will examine the role of a mitochondrial membrane protein known as phosphoglycerate mutase 5 in intestinal epithelial radiosensitivity. A novel small molecule-based modulator of this membrane protein function will be tested as a radiation countermeasure against radiation induced acute gastrointestinal syndrome. Successful completion of this project will lead to the development of this small molecule-based therapy as a new medical countermeasure to treat injuries resulting from a radiation or nuclear accident.